NMRFx: An Integrated software suite for macromolecular NMR analysis

Knowing the structure, dynamics and ligand binding specificity of proteins and nucleic acids is essential to understanding the mechanisms of human disease and to the optimal design of molecules that can intervene therapeutically in disease processes. Nuclear Magnetic Resonance (NMR) Spectroscopy is one of the most versatile techniques for obtaining this molecular information. This tremendous value of NMR in biomedical science is only realized through the application of powerful computational tools. Our goal in this project is to extend and harden three existing software programs for the computational analysis of NMR data into a powerful, but user-­friendly, integrated suite. Having effective software for NMR, as we are proposing, is especially critical as we realize that the deep insight into macromolecular structure and function comes not from a single technique like NMR, but from the complementary information from various techniques including NMR, X-­ray crystallography, and Cryo-­electron microscopy. Scientists are no longer seeing these techniques as specialized techniques usable by only domain experts, but as a collection of techniques that can and should be applied together. Despite this essential role for NMR and the key need for accessible computational tools in its use, there does not exist an integrated software environment that spans the major steps of macromolecular NMR analysis. Researchers must use a variety of tools from different labs that have different programming languages, scripting tools, naming conventions, graphical interfaces, documentation styles etc. The project proposed here aims to resolve this important issue by the further development and hardening of three existing software applications, all previously developed by the PI, into an integrated software suite, NMRFx. NMRFx Processor will provide the signal processing necessary to transform NMR data into usable spectra. NMRFx Viewer will provide advanced tools for visualizing and analyzing the NMR spectra. NMRFx Structure will allow calculating macromolecular structures consistent with the data, and calculating structure dependent NMR properties such as chemical shifts. Integrating the tools will not only make their use more accessible and efficient, but tight integration will allow new approaches to computational analysis that move away from the traditional linear sequence of steps into a more holistic approach to extracting information from the data. Development of the integrated software platform proposed here will substantially lower the barrier and better support new users in accessing the important information that NMR can provide. We propose that by providing new, and even experienced users, with a software toolset that has a common installation protocol, interface style, data structures, and overall design, we can substantially lower these barriers to use. Doing this will make the use of NMR techniques more accessible to a wider population of researchers and increase the use of NMR in a broad range of biological research areas that impact on human health.

Public health relevance
Knowing the structure, dynamics and ligand binding specificity of proteins and nucleic acids is essential to understanding the mechanisms of human disease and to the optimal design of molecules that can intervene therapeutically in disease processes. Nuclear Magnetic Resonance (NMR) Spectroscopy is one of the most versatile techniques for obtaining this molecular information. This research will extend and harden an integrated, software suite for processing, analyzing, and using NMR data, and thereby make the use of these techniques faster and more accessible to a wider population of researchers.